Targeted Near-infrared Fluorescent Probes for Detection of Ovarian Cancer Lesions

[unreadable] DESCRIPTION (provided by applicant): Ovarian Cancer (OC) is one of the deadliest gynecological cancers. The current screening approach for OC detection relies on measuring the blood level of ovarian cancer-specific antigen CA125, the only OC marker that is approved for clinical use. The strategy for OC management includes a combination of surgical treatment with chemotherapy regimens. Detection of primary and secondary OC lesions is very important for early diagnosis and effective surgical treatment. We propose to develop a novel class of targeted fluorescent probes that will specifically recognize tumor markers on the surface of OC cells. We will use near infrared (NIR) indocyanine fluorophore Cy5.5 conjugated to targeting moieties that recognize CA125. This targeting is expected to accentuate differences between normal and cancerous tissues significantly. The advantage of our approach is that the proposed targeting moieties are smaller in size than antibodies, non-toxic and non-immunogenic and could be selected and produced faster than traditional antibodies. Small size will provide better and faster tissue penetration and would shorten the time between administration of the fluorescent agent and its detection. Application of the proposed approach will facilitate early detection of OC in the high risk group of patients and will increase selectivity of surgical procedures without compromising tumor removal efficiency of the surgery. Survival and quality of life of ovarian cancer patients mostly depends on early detection and effective surgical treatment of the disease. Optical methods for detection of ovarian tumors and their metastasis are essential clinical tools for detection of the disease, surgical eradication and monitoring treatment progress. We will develop a novel class of targeted fluorescent probes that will dramatically increase sensitivity and specificity of optical methods. [unreadable] [unreadable] [unreadable]